IDENTIFICATION OF ORTHOPOXVIRUS-DERIVED CD8+ T CELL EPITOPES MACAQUES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. We completed analysis of immune responses in an additional vaccinated animal and published a manuscript describing these findings. AIDS Related.